ClinGen AI Data Delivery Supplement

PROJECT SUMMARY
The National Library of Medicine’s ClinVar repository is the world’s most robust source of curated
clinical variant assessments. It contains classifications of over 2 million variants with 96% from clinical
laboratories and ~5,000 curated via the Clinical Genome Resource’s (ClinGen) expert panels. In addition,
ClinGen maintains a database of expert-curated gene-disease relationships, which are accessible through
ClinGen’s website, as well as deposited in the Gene Curation Coalition (GenCC) database that allows
submissions from any source and contains nearly 17,000 claims on ~4,700 genes. Further, ClinGen has
developed open-source interfaces for both variant and gene curation that collect the detailed information
needed for classification.
While the data from these sources is incredibly valuable to accurate identification of disease-causing
variation, in its current state it contains some important limitations. Namely, due to the repository nature of
these data sources, many of the laboratory submissions to ClinVar are outdated and some of the gene-disease
submission to GenCC and variant submissions to ClinVar have missing evidence or used old or misapplied
current classification frameworks. This can lead to discrepancies in the classifications across labs, decreasing
the utility of the resources. While efforts are underway to resolve discrepancies by having laboratories
reclassify discordant interpretations, this work is time-consuming and therefore slow to resolve at scale.
The parent ClinGen award’s specific aims are: (1) develop and implement standards to support clinical
annotation and classification of genes and variants, (2) share genomic and phenotypic data between clinicians,
researchers, and patients through enhanced knowledge bases for clinical and research use, (3) enhance and
accelerate expert review of the clinical relevance of genes and variants, and (4) disseminate and integrate
ClinGen knowledge and resources to the broader community.
The work proposed here is within the scope of the parent grant, though represents work not planned
and will support all of these aims by developing methods and software to transform ClinVar, ClinGen and
GenCC data extracts into formats that can be easily targeted by machine learning algorithms. Our aims are
threefold. We will: (1) develop formats that that are easily digestible by traditional machine learning
approaches, (2) make it easier to use these data in generative AI approaches and (3) evaluate the ability of
Large Language Models (LLM) to extract data used in variant classification and write accurate, robust variant
evidence summaries. We will also implement the GA4GH Variant Representation Specification (VRS) to lay
the groundwork for integration with other genomic data sources.

Public health relevance
PROJECT NARRATIVE Hundreds of thousands of disease-causing changes have been identified in the DNA of individuals with disease, yet only a fraction of those changes, and their associated interpretations, are accessible to researchers, clinicians, and patients. This proposal will facilitate machine learning applications of ClinGen’s successful foundation to collect, organize, and interpret genomic evidence from global sources and distribute the resulting knowledge into publicly accessible databases for use in medicine and research.